Race & Place: The Impacts of Racial Inequality on Substance Use and HIV Outcomes in Los Angeles

ABSTRACT
It is well established that racial disparities in HIV care outcomes and use of substances among sexual minority
men (SMM) of color persist because of structural racism in Los Angeles County (LAC). Furthermore, we know
accessible, comprehensive, and culturally congruent healthcare is key to achieving racial equity in HIV and
substance use (SU) outcomes. Preliminary research, including our own studies, indicate major barriers to care
include hard to reach locations of HIV and SU care, transportation challenges across large urban settings such
as LAC, and lack of congruence with HIV care staff. While research shows that healthcare access is important,
there are mixed responses of where Black and Latinx SMM (BLSMM) prefer to receive care. These findings
underscore the need for healthcare experiences that address geographic challenges and are culturally
appropriate. Understanding how structural racism influences how BLSMM navigate the geography of LAC to
receive SU and HIV care and how peer case managers, with racial and SU congruence, may enhance access
to care will provide novel insights into the relationship between racism and HIV and SU treatment. We propose
research and adaptation of an evidence-based intervention LINK-LA built on an established NIDA-funded
cohort of BLSMM, The mSTUDY (U01DA036267), and preliminary findings of an R21 on spatial connections
conducted by this multi-disciplinary research team (DA049643). Using intersectional anti-racism frameworks
the Public Health Critical Race Praxis (PHCR) and the socio-ecological model of health and mixed methods,
we will interrogate how 1) historical racist practices influence unequal spatial patterns and how such unequal
structural factors are associated with distinct patterns of movement across social and geographic space among
BLSMM in LAC and how these patterns influence where people with HIV (PWH) elect to receive care; (2) and
how peer case managers who bring access to services and support to participants in the neighborhoods of
their choice in LAC enhances use of services, their contextual outcomes, and HIV and SU outcomes by
adapting an EBI Link-LA. Our proposed study directly fits with NIDA’s Racial Equity Initiative (REI). The
proposed study will extend ongoing collaborations between the University of California, Los Angeles (UCLA),
the University of California, Santa Barbara (UCSB) team, and will be co-led by the Los Angeles LGBT Center
resulting in a community-based research program design that is directly informed by and responsive to
community needs. This collaborative team of scientists includes MPIs across all three career levels and
community-based practitioners that represent an intentionally interdisciplinary and comprehensive response to
RFA-DA-23-061. Findings will be used to establish enhanced healthcare delivery models that improve racial
equity and reduce HIV care disparities.

Public health relevance
PROJECT NARRATIVE In response to RFA-DA-23-061 we propose “Race & Place: Impacts of Racial Inequality on Substance Use and HIV Outcomes in Los Angeles” to investigate how historically racist policies and practices affect current Black and Latinx Sexual Minority Men in Los Angeles, how the introduction of peer case management may help reduce some of the barriers in terms of access to HIV care, substance use, food and housing, and in turn how these may improve HIV and substance use outcomes. Our team includes the LA LGBT Center, the largest LGBT Serving community site in the country to ensure that evidence-based research is targeted where it in needed the most. Capitalizing upon cross-cutting expertise with academic and community partners to articulate the drivers of the ongoing HIV epidemic among the most vulnerable populations in the US, we will identify strategies to address the intersectionality of this ongoing public health crisis.